Cancer Prevention and Control Research Training and Career Development Program

PROJECT SUMMARY-ABSTRACT
The University of Texas Health Science Center at Houston (UTHealth) School of Public Health seeks its
sixth renewal of our highly successful Cancer Control Research Training and Career Development Pro-
gram for doctoral students and postdoctoral trainees. The long-term goal of the proposed training pro-
gram is to reduce cancer morbidity and mortality and decrease cancer-related health inequities. The
training program objective is to increase the number of outstanding cancer control scientists - with an
emphasis on training scientists from underrepresented minority groups - in cutting edge research and
analytic skills. The training program is designed to prepare cancer prevention and control researchers to
fill evidence gaps about multi-level causes of cancer-related inequities; to develop and evaluate cancer
control multilevel interventions (MLIs); and develop and test strategies to increase the adoption, imple-
mentation, sustainment, and scale up of effective interventions in community and health care settings.
The proposed program renewal builds on a 29-year track-record preparing fellows (many from un-
derrepresented minority groups, 44% currently) to become independent, skilled, and principled cancer
control scientists. Using exceptional innovative instruction, mentored learning experiences, professional
development skills, participatory research processes, and hands-on experience in diverse settings, the
proposed training program prepares fellows to conduct pragmatic, actionable, research that addresses
cancer-related health inequities. Outstanding cancer control researchers participating as mentors and co-
mentors have created long-standing community and healthcare research partnerships across the state,
nationally, and globally, and a wide variety of cancer-related funding from diverse federal and non-federal
sources providing unparalleled opportunities for trainees. Key areas of the program include: (1) training
on the use of large databases such as healthcare claims, EHRs, surveys, and cancer registry data to iden-
tify multi-level cancer-related determinants; 2) training on innovative research design and analytic skills
such as geo-spatial analysis, systems science, Bayesian approaches, ecological momentary assessment,
and pragmatic trial designs, to tackle the multilevel, multidimensional, factors influencing cancer; 3) the
development and evaluation of MLIs using community based participatory research and systematic plan-
ning; and 4) training on adaptation of cancer control interventions, and the design and testing of imple-
mentation strategies. By the end of the current cycle, our program will have graduated 68 fellows and 5
fellows will continue their training in the next cycle. In this renewal, the training program will appoint 15
new trainees, supporting approximately 4 predoctoral and 4 postdoctoral positions annually. Building on
a strong track record, the program will continue to recruit, retain, and train minority pre- and postdoc-
toral fellows with a strong commitment to research for the elimination of cancer-related health inequities.

Public health relevance
PROJECT NARRATIVE The sixth renewal of the University of Texas Health Science Center at Houston (UTHealth) School of Public Health training program builds on a 29-year track-record preparing fellows (many from underrepresented minority groups) to become independent, skilled, and principled cancer control scientists. The training program is designed to prepare cancer prevention and control researchers to fill evidence gaps about multi- level causes of cancer-related inequities; to develop and evaluate cancer control multilevel interventions (MLIs); and develop and test strategies to increase the adoption, implementation, sustainment, and scale up of effective interventions in community and health care settings. Ultimately, the long-term goal of the proposed training program is to reduce cancer morbidity and mortality and decrease cancer-related health inequities.